TWO DOSAGE REGIMENS OF ORAL DAPSONE FOR PROPHYLAXIS OF PNEUMOCYSTIS PNEUMONIA

Comparison of two dosage regimens of oral Dapsone for prophylaxis of pneumocystis carinii pneumonia in pediatric HIV infection.